Chemical Synthesis of Chiral Bioactive Molecules

Abstract Not applicable. Please refer to the Research Strategy section for the abstract of the parent grant.

Public health relevance
Narrative Equipment Administrative Supplement - Not applicable